PREPARATION OF THE REPORT ON CARCINOGENS

As mentioned in the specific aims, the objective of this contract is to procure assistance in preparing the Report on Carcinogens (RoC) and the background documents used in the review of substances under consideration for possible listing and delisting in the RoC (that is candidate substances). The National Toxicology Program (NTP) has been conducing scientific reviews for candidate substances for the Twelfth RoC over the last several years, and completed these reviews in fiscal year 2010. The NTP submitted the draft Twelfth RoC to the NTP executive committee for review, and plans to submit it to the Secretary, Department of Health and Human Services in early fiscal year 2011. SRA (formally Constella) has provided support for the preparation of the Twelfth RoC. Specifically, the have provided support for convening one expert panel and finalizing the background document based on the peer review comments of the panel. They have also provided support for updating and editing the information for substances already listed is the Eleventh RoC (which has been ongoing task), and for desktop publishing activities for the Twelfth RoC.